In Vitro/In Vivo: Contract Orientation meeting with NCI, Office of Acqustions

To hold an administrative meeting with the Office of Acqustions to discuss administative matters for the Preclinical In Vitro and In Vivo Agent Development Assays